Dynamic Biomaterial Design to Probe the Cellular Response to Fibrotic Stiffening

PROJECT SUMMARY
Despite the ubiquitous role of fibrosis in tissue dysfunction arising from aging and disease, no representative
in vitro model of the fibrotic microenvironment exists. Fibrosis is characterized by excess extracellular matrix
(ECM) deposition that stiffens the cellular microenvironment. Therefore, to model fibrosis in vitro, cell culture
substrates that permit quantitative, dynamic tuning of matrix mechanics are necessary. However, existing
dynamic hydrogel culture platforms generally rely on chemistries that may be toxic to cells or that simultaneously
change multiple parameters, making it difficult to assign causal relationships between altered matrix properties
and cell fate changes. Fibrotic stiffening occurs in a wide range of tissues, including the skeletal muscles, liver,
lungs, and heart. Numerous genetic cardiomyopathies are characterized by progressive fibrotic stiffening that
precedes heart failure. While fibrotic stiffening is known to impair the heart’s ability to pump blood, the impact of
stiffening on the phenotype of individual cardiomyocytes remains poorly understood. The goal of this research
proposal is to develop an in vitro model of tissue fibrosis based on dynamic hydrogel biomaterials that enables
real time measurement of cellular dysfunction to determine how progressive fibrotic stiffening detrimentally
impacts cell fate. As a model system, we will interrogate the effects of stiffening on human cardiomyocytes
differentiated from induced pluripotent stem cells from Duchenne muscular dystrophy (DMD) patients. DMD is
an ideal model system for studying outside-in mechanosignaling, as DMD arises from a lack of dystrophin, a
structural protein linking the contractile cytoskeleton to the ECM. We will use the dynamic hydrogels developed
during this research to assess contractile dysfunction, aberrant activation of mechanotransduction signaling, and
novel molecular mechanisms of “mechanical memory” arising from fibrotic stiffening.
In Aim 1, we will develop a synthetic hydrogel system that uses near-infrared light and bioorthogonal
reactions to dynamically stiffen the gels, mimicking fibrosis. These hydrogels will be used to determine how
contractile dysfunction arises from fibrotic stiffening. In Aim 2, we will determine how increased stiffness alters
biochemical signaling in cardiomyocytes, focusing both on “canonical” mechanotransduction through Rho
GTPases and YAP signaling and on a new mechanosensitive pathway in actively contracting cells that involves
mechanical generation of reactive oxygen species (ROS), DNA damage, and impaired mitochondrial biogenesis.
In Aim 3, we will investigate the first example of “mechanical memory” in cardiomyocytes. We will develop a
hydrogel platform that is stiffened by one wavelength of light and subsequently softened by a second wavelength.
This system will enable identification of molecular mechanisms by which exposure to a stiffened
microenvironment causes persistent cellular dysfunction and strategies to reverse this memory. The engineered
platforms developed will be broadly useful for studying fibrosis in progressive genetic diseases as well as aging.

Public health relevance
PROJECT NARRATIVE Fibrosis, or scarring, causes dysfunction and ultimate failure of numerous tissues with aging and disease, and is characterized in part by increased tissue stiffness. Despite estimates that fibrosis contributes to 45% of U.S. deaths, no adequate model system exists to study fibrotic stiffening on individual cells in real time. This project aims to develop novel dynamic material platforms that enable user-directed manipulation of stiffness and to apply these systems to identify the molecular mechanisms by which fibrotic stiffening leads to cellular dysfunction.